Determining the Molecular Arrangement of GABABR-GIRK Signaling Cascades

Project Summary/Abstract
Drug addiction is marked by functional changes to once healthy cell signaling pathways. Drugs of abuse such
as morphine, cannabinoids, cocaine, and gamma-hydroxybutyrate (GHB) disrupt inhibitory neurotransmission
signaling through G protein-coupled inward rectifying potassium (GIRK) channels. In fact, while some
substances like alcohol bind directly to GIRK, the channels are also directly downstream of G protein coupled
receptors (GPCRs) which make up the largest class of drug targets for FDA approved pharmaceuticals.
GPCRs, heterotrimeric G proteins of the Gi/o family, and GIRK channels are linked by a series of distinct
protein-protein interactions, and a substantial proportion of inhibitory neuromodulation is mediated by this
pathway. One major inhibitory GPCR found in the hippocampus called GABAB receptor (GABABR) initiates a
series of conformational changes that propagates through the signaling cascade resulting in GIRK channel
opening. While individual subunit interactions have been studied, no consensus on the comprehensive
macromolecular organization of this signaling pathway has been reached. GHB, a drug of abuse, acts as a
weak agonist at GABABR and in high doses induces sedation and euphoric effects. Understanding how
GABABR and GIRK channel proteins interact and are organized as a signaling cascade will provide valuable
insight into how inhibitory signals are sensed, propagated, and transmitted. Significantly, GABABRs and GIRK
channels have been shown to co-localize and interact in neurons, and both GABABR and GIRK channels form
complexes with inhibitory G protein subunits. Thus, this proposal plans to test the hypothesis that GIRK
channel activation consists of a preformed complex that is rearranged upon GPCR/G protein activation. To test
this hypothesis, I will use optical biosensors and GIRK signaling assays in Gα null cells to define the functional
signalosome. Additionally, I will define the protein-protein binding interfaces within the complex using
crosslinking-mass spectrometry. Finally, I will determine how the protein-protein interactions change from the
inactive to the fully active signaling state. Taken together, this project will provide a clear understanding of how
inhibitory GABAB-G protein-GIRK signaling occurs and more broadly, how drugs such as GHB hijack GPCR-
ion channel dynamics.

Public health relevance
Project Narrative Inhibitory neuronal signaling from drugs binding GPCRs often results in GIRK channel activation by Gi/o heterotrimeric G proteins. Understanding how GABAB receptors activate G proteins which in turn activate GIRKs is of critical importance to understanding drugs of abuse involving inhibitory signaling. We propose a large, preformed complex between receptors, GIRK channels, and heterotrimeric G proteins that allows efficient activation and deactivation neurons, and this project will define this inhibitory signaling complex.